The Role of E3-Ubiquitin Ligase Complex in Genitourinary Tract Development and Function

Summary: Despite their high prevalence, the molecular basis for common genitourinary (GU) congenital defects
is poorly understood. We have identified and validated gene lesions at the KCTD13/16p11.2 locus as
responsible for lower GU tract abnormalities, particularly cryptorchidism and hypospadias. KCTD13
encodes a substrate-specific adapter of a BCR (BTB-CUL3-RBX1) E3 ubiquitin-protein ligase complex, which
regulates the actin cytoskeleton and cell migration via ubiquitination and degradation of RHOA. Notably, RHOA
has been implicated in the maintenance of Sertoli-germ cell junctions to promote gametogenesis and gonads
development. E3 ubiquitin ligases also regulate the androgen receptor (AR), which is key to male genitalia
development and differentiation. We found that KCTD13 is robustly expressed in the GU tract and have recently
shown that in comparison to normal controls, gene copy number variants are remarkably common in patients
with GU birth defects. Moreover, we obtained in vitro and in vivo evidence that KCTD13 loss affects AR levels
in testis and penis. We also observed that haploinsufficient and Kctd13 deficient mice had significantly higher
incidence of cryptorchidism and decreased size of testes, seminal vesicles and penis size in conjunction with
spermatogenic defects, causing severe subfertility. Further, Kctd13 null mice revealed a significant decrease in
masculinization factor SOX9 levels and concomitant upregulation of the feminization factor RHOA. While our
collective data suggest a key role of KCTD13 in male GU development, the mechanisms of how this molecule
impinges upon the AR and/or SOX9 axes remain a major gap of knowledge. We hypothesize that gene dosage
changes in KCTD13 alter the signaling of the masculinization axes, leading to abnormal GU tract
development, defective gonad formation, undervirilization, and subfertility. In line with our reasoning, we
will test two plausible independent mechanisms by which KCTD13 mediates lower GU tract development and
differentiation. First, we hypothesize and test that gene dosage changes in KCTD13 affect GU tract development
by affecting AR degradation, subcellular localization and downstream gene targets (AIM 1). Second, we
hypothesize and test that KCTD13 affects the expression of masculinization factor SOX9 directly by modulating
SOX9 ubiquitination or indirectly by regulating RHOA degradation, which in turn leads to defects in testis and
penile development and differentiation (AIM 2). Finally, we identify and characterize the mutations in KCTD13-
CUL3 pathway that are critical in GU development such that they could be used to generate a diagnostic kit for
patients with disorders of sexual development (AIM3). Completion of the studies in this proposal will advance
our understanding of the molecular mechanisms that underlie common GU birth defects.

Public health relevance
PROJECT NARRATIVE: Although birth defects of the genitourinary (GU) tract are common, the cause of such defects remains largely unknown. This study aims to understand the causes of common GU tract birth defects by identifying new genes that may play a role in development of the urinary tract.